Early response to radiotherapy and immunotherapy in rectal cancer: an integrated molecular, cellular, and spatial approach

Project Abstract
With increased incidence in young populations and ~65% three-year survival of high-risk locally advanced rec-
tal cancer, innovative approaches to improve outcomes is imperative. Neoadjuvant therapy with radiation (RT)
and chemotherapy (CT) is now the standard curative treatment, but there is demand for non-operative man-
agement (NOM) if the disease can be cured with local and systemic therapy. Thus, innovations could be trans-
formative with the aim to improve durable complete responses by personalizing therapy, which includes how to
deliver RT, CT, and the incorporation of novel agents such as immunotherapy. Cancer Immunotherapy has
had little impact on colorectal cancer outside of mismatch repair deficient tumors. The αCD40 agonist antibody
is an emerging class of immunotherapy and sotigalimab has shown promise in phase I and multiple ongoing
phase II trials. The CD40 receptor is important in both innate and adaptive immune responses and a greater
therapeutic effect can be achieved combining αCD40 with RT in animal models. We hypothesize that short
course RT (SCRT) and CT when combined with αCD40 in human tumors can result in a greater antitumor im-
mune response, reduce risk of metastatic progression, and extend survival in a poorly immunogenic malig-
nancy like rectal cancer. We developed the INNATE trial, a phase II randomized trial of neoadjuvant SCRT fol-
lowed by CT with or without the addition of sotigalimab for locally advanced rectal cancer. This trial design has
allowed us to collect fresh pre- and post-SCRT biopsy tissue, which we have obtained from 21 of 30 patients
enrolled to date. In this proposal, we focus on the central hypothesis that an integrated molecular, cellular, and
spatial assessment of treatment response dynamics in the tumor microenvironment early after SCRT can re-
veal insights into the immunobiological responses, which can inform mechanisms of efficacy and therapeutic
selection. We will perform 1) molecular and cellular single cell (sc) RNAseq with proteomic and immune reper-
toire analysis, 2) molecular, cellular, and spatial multiplex immunofluorescence, and 3) cellular and spatial
quantitative deep learning based histopathologic analysis to achieve our aims. These three technologies will
enable us to investigate early changes across RT and αCD40 treated groups. Then we will aim to identify ther-
apeutic opportunities for the combination of SCRT with immune active agents though an integrated RT re-
sponse assessment. Lastly, we will establish innate and adaptive immunologic signaling events triggered by
SCRT in combination with αCD40 immunotherapy and factors that enhance or hinder efficacy. We will use
models to start validating key findings and aim to propose future therapeutic directions to build off these efforts
and ultimately improve outcomes. Specifically, regarding our patient population, we expect this proposal will
lead to evidenced based trials for most patients with locally advanced rectal cancer who strive to achieve cure
without a morbid surgery.

Public health relevance
Project Narrative Developing optimal radiation and immunotherapy combinations is hindered by the limited ability to deeply understand therapeutic responses and there is a critical need to innovate with rectal cancer when cure with radiation and systemic therapy could save a morbid surgery. We have developed an integrated approach to assess early biopsy tissue after short course radiation therapy to assess molecular, cellular, and spatial dynamics that could improve our ability to nominate promising therapies. With pre- and post- therapy biopsies from our αCD40 trial, we will perform single cell RNA sequencing, multiplexed immunofluorescence, deep learning from histopathologic tissue to identify therapeutic opportunities and study mechanisms of response to αCD40.